Resource Core

PROJECT SUMMARY/ABSTRACT
Coriell Institute for Medical Research (Coriell) proposes to maintain and expand the NIGMS Human Genetic
Cell Repository (HGCR). The NIGMS HGCR, established in 1972 at Coriell by the National Institute of General
Medical Sciences (NIGMS), provides a readily accessible, centralized resource for biospecimens from
individuals with inherited disorders, chromosomal abnormalities, apparently healthy individuals, and individuals
of diverse geographic origins for use in biomedical research. The primary goal of the NIGMS HGCR is to
stimulate and facilitate biomedical research, teaching, and the diagnosis and prevention of human genetic
diseases by establishing and maintaining a repository of high quality, uncontaminated, well characterized, and
clinically well-documented cell lines and DNA and making these resources available to investigators
throughout the U.S. and abroad. The NIGMS HGCR mission is in line with the NIGMS mission, which is “to
support research that increases understanding of life processes and lays the foundation for advances in
disease diagnosis, treatment and prevention”. The NIGMS HGCR’s activities, all governed by high standards
of quality, will include (1) collection, establishment, characterization, maintenance, and distribution of cell lines,
(2) preparation, storage and distribution of DNA from cell lines, (3) the development and offering of special
genetic services and biomaterials in response to customer requests, (4) maintenance of a comprehensive
database and online catalog, and (5) publicizing the NIGMS HGCR’s collections. The NIGMS HGCR will
maintain, grow and distribute the current collection of approximately 11,900 unique cell lines, 6,000 DNA
samples, and 140 human iPSC lines in its online catalog, as well as newly acquired resources. The NIGMS
HGCR will continue to create human induced pluripotent stem cell (iPSC) lines at Coriell by reprogramming
certain NIGMS HGCR cell lines. Additionally, Coriell is committed to integrating state-of-the-art technologies
into its activities and will continue to offer a wide range of cutting edge services that enhance the utility of the
HGCR collection to the genetic research community.

Public health relevance
PROJECT NARRATIVE The NIGMS Human Genetic Cell Repository (HGCR) stimulates and facilitates biomedical research, teaching, and the diagnosis and prevention of human genetic diseases by providing well-characterized and high-quality cell lines, DNA, and iPSCs for use in biomedical research. The NIGMS HGCR currently contains approximately 11,900 unique cell lines, 6,000 DNA samples, and 140 human iPSC lines representing a variety of disease states, chromosomal abnormalities, apparently healthy individuals and many distinct human populations. The NIGMS HGCR also develops and offers a wide range of cutting-edge special genetic services and biomaterials in response to the research community’s needs.